EFFECT OF AN ACUTE INSULIN INFUSION ON METABOLIC CLEARANCE RATE (MCR) OF DHEA

To assess the effect of an acute insulin infusion on the metobolic clearance rate of dehydroepiandrosterone in elderly men and women.